Enhancing accrual across gynecologic and solid tumor trials

PROJECT SUMMARY/ABSTRACT
My clinical research program focuses on improving the lives of all women with gynecologic malignancies. I
serve as the lead for the clinical trials program in Gynecologic Oncology (GYO) and as institutional Principal
Investigator (PI) for the NRG/NCTN. My position in the University of Virginia Comprehensive Cancer Center
(UVACCC) and the UVA School of Medicine (SOM) is unique. I spend 50% of my effort as a practicing
Gynecologic Oncologist and clinical researcher, where I maintain a thriving surgical and chemotherapy
practice. The other 50% of my effort is spent as Associate Dean for Clinical Research for the SOM. In this role,
I oversee the building and maintenance of all clinical research infrastructure, including the Clinical Trials Office,
which serves the entire SOM. I am therefore uniquely positioned to conduct clinical research as well as build
critical clinical research infrastructure for the UVACCC and the entire SOM. This award will allow me to
decrease my surgical activity to focus on the following three goals: (1) Increase UVACCC accrual depth and
breadth in NCTN/ETCTN clinical trials by identifying and overcoming both provider and patient barriers; (2)
Increase UVA leadership and collaboration in new clinical trials through the NCTN/ETCTN mechanism via
mentorship and partnership with translational researchers and multi-disciplinary groups; and (3) Capitalize on
my role in the Dean’s office and my own clinical research expertise to streamline clinical trial development,
review, and activation in the SOM. I will achieve these goals by leveraging my dual strengths in clinical
research and mentoring young investigators along with my administrative role in the Dean’s office, which will
enable me to build additional infrastructure school-wide. These activities will increase UVA’s involvement in
NCTN/ETCTN trials to benefit all patients treated at UVACCC.

Public health relevance
Linda Duska, MD, MPH is an experienced and prolific Clinical Scientist whose overall research goal is to improve the lives of patients with gynecologic cancer and other solid tumors by offering opportunities to participate in clinical research and by developing novel biomarker driven therapies through the clinical trial mechanism. The goal of this proposal is to increase both overall accrual and state-wide access to nationally sponsored clinical trials at the University of Virginia Comprehensive Cancer Center (UVACCC) and to increase UVA’s leadership and collaboration in new clinical trials within the national framework. These goals overlap with the goals of the UVACCC, which include increasing accrual and state-wide access, as well as building multidisciplinary teams focused on a biomarker-driven approach to clinical research.